Genetic regulation and immunological function of ERAP2 haplotypes

We propose to dissect the genetic control and immunological function of ERAP2, a gene previously shown to
play a role in antigen processing. Two haplotypes at the ERAP2 locus have been maintained by natural
selection in humans where the more frequent haplotype (Haplotype B) is associated with risk for Crohn's
disease, ankylosing spondylitis, preeclampsia and HIV susceptibility. Enigmatically, while Haplotype A encodes
a full-length enzyme that cleaves viral peptides for antigen presentation, Haplotype B encodes a transcript
efficiently degraded by nonsense-mediated decay. Why would natural selection have maintained a seemingly
loss-of-function version of the gene and by what mechanism would it cause disease? We found a possible
explanation by studying the antiviral response of monocyte-derived dendritic cells in 250 healthy individuals. In
response to in vitro stimulations, influenza infection induced the transcription of two unannotated short isoforms
from Haplotype B that are not observed in resting or interferon-beta stimulated cells. This observation,
combined with previous immunological results and evidence of natural selection, leads us to hypothesize that
the two ERAP2 haplotypes encode distinct gene products that play divergent roles in viral antigen processing
and presentation. In this proposal, we will apply state-of-the-art molecular and immunological tools to test this
hypothesis. In Aim 1, we will use functional genomic techniques (long-read RNA-seq, ribosomal footprinting
and proteomics) to characterize the transcriptional and translational properties of ERAP2 in response to a
spectrum of viral challenges. In Aim 2, we will map the cis-genetic control of ERAP2 using reporter assays and
CRISPR/Cas9-mediated genome editing. In Aim 3, we will measure how different ERAP2 isoforms affect
antigen presentation and T cell function. Our findings will shed new light on the regulation and function of the
ERAP2 haplotypes and contribute to the understanding of how genetic variants under natural selection could
cause autoimmune disease.

Public health relevance
The evolutionary arms race between host and pathogen genomes has left a genetic imprint at the ERAP2 locus where a version of the gene that conferred a fitness advantage in a historical environment is now associated with autoimmune disease. The goal of this project is to dissect the function of different versions of ERAP2 by studying their regulation in response to viral infection and their effects on the adaptive immune system. Results from this study will shed new light on the evolution of the human immune system and the role of ERAP2 in infectious and autoimmune disease processes.